DMID Clinical Research Operations & Management Support (CROMS): mpox activities

This program provides resources and services in support of clinical research to DMID and DMID-supported investigators and fulfills DMID’s regulatory obligations for clinical research oversight. Support provided includes clinical site support, site quality management, essential regulatory document review and storage, clinical site monitoring, training, safety, data and safety oversight committees, and quality management.